Core 2: Pathology and Tissue Core

Core 2
Specific Aims
The primary objective of the M.D. Anderson Cancer Center (MDACC) Leukemia Spore is to improve the
treatment of patients with leukemia. A fundamental component to meeting this objective is the conduct of focused
translational research involving human tissue and blood specimens, allowing investigation of the biology of target
and normal tissues, evaluation of treatment effects on both target and normal tissues, and modulation of relevant
biomarkers. To these ends, the Leukemia Sample Distribution, Banking and Array Profiling Core (hereafter Core
2), will collect, process and maintain human tissue specimens from patients and will disperse these tissues to
Leukemia Spore investigators. The Core will also provide genome-wide molecular profiling of RNA and protein
expression, which provide insights into cellular physiology such as signaling pathway activity.
The AML Tissue Sample, Distribution, Banking and Array Profiling Core has the following objectives:
1. Develop and maintain a repository of intact cells, serum, DNA, RNA and protein from blood and bone
marrow specimens obtained from AML patients at MDACC.
2. Maintain a comprehensive, prospective, interactive online database with detailed clinical and pathologic
data for the samples received by the Core.
3. Provide Reverse Phase Protein Arrays (RPPA) from AML patient samples for screening of protein
expression in bulk leukemia cells, leukemia stem cells, and mesenchymal stromal cells (MSC).
4. Provide RNA-Seq data interpretation for gene expression profiling (GEP).
5. Facilitate inter- and extra- Leukemia Spore collaborations through sharing of blood and marrow resources.

Public health relevance
Narrative The Core provides patient derived blood and marrow specimens, acquired at diagnosis, during therapy, or at time of progression, that are required for all 5 projects to fulfill their specific aims. Additionally the core provides array profiling services for RNA-seq and protein to projects 3, 4 and 5. Without this service and these samples the grant cannot succeed.